BASE IDIQ TITLE: TECHNICAL, PROGRAMMATIC AND OTHER SUPPORT SERVICES TO THE NCI CSSI.TASK ORDER TITLE: NCI OCCPR WEBSITE MAINTENANCE

This task order is for the website maintenance service to NCI Office of Cancer Clinical Proteomics Research (OCCPR).